Optimizing immunoradiotherapy for HNSCC

Project Summary
Head and neck squamous cell carcinoma (HNSCC) is driven by tobacco, ethanol and other carcinogens as well
as oncogenic human papilloma virus (HPV). In particular, HPV negative HNSCC has a high rate of mortality and
the main curative treatment options for local and regional disease, including surgery, radiation, and
chemotherapy, incur significant morbidity. PD-1 inhibitors are approved for recurrent/metastatic HNSCC yet have
low response rates of 14-20%. Furthermore, a recent Phase III trial demonstrated no benefit when a PD-1
inhibitor was combined with chemoradiation using large radiation fields targeting tumor and lymph nodes. While
the tumor immune microenvironment is key to the activity of immunotherapy, the role of draining lymph nodes in
the efficacy of immunotherapy is poorly understood and the impact of conventional therapies anti-tumor immunity
deserves further investigation. Our preliminary data demonstrate nodal irradiation or surgical removal of draining
lymph nodes completely blocks the anti-tumor activity of PD-1 inhibitors, and surgical disruption of lymphatic
channels alone while maintaining intact draining lymph nodes also blocks immunotherapy responses.
Mechanistically, we have identified cDC1 and B-cell antigen presenting cells in draining nodes as key immune
effectors coordinating anti-tumor immune responses. Further, a Phase I trial of immunoradiotherapy using PD-1
inhibitors combined with lymphatic sparing stereotactic radiation (SBRT) demonstrates a remarkable 67%
complete pathologic response rate in HNSCC patients. Our central hypothesis is that intact, functional
draining lymphatics and lymph nodes are critical for anti-tumor immunity and that lymphatic preserving
IRT in HNSCC will maximize anti-tumor responses. To explore this hypothesis, we will use animal models of
HPV negative HNSCC to 1) determine the role of the draining sentinel lymph nodes in generating and
coordinating immune responses during immunotherapy and SBRT based immunoradiotherapy in HPV negative
HNSCC, and 2) maximize immunotherapy responses in HNSCC by optimizing treatment sequencing, radiation
targeting, and enhancing antigen presentation in draining lymph nodes. To validate this hypothesis in patients,
we will define immune phenotypes that correlate with major pathologic responses from a clinical trial of
neoadjuvant immunoradiotherapy in HPV negative HNSCC patients. Completion of this project will elucidate the
role of draining sentinel lymph nodes in coordinating anti-tumor immune responses, identify optimized
sequencing and novel combinatorial immune therapies in HNSCC, and define immune signatures in patients
with complete responses to immunoradiotherapy in HSNCC. These insights will guide and improve the design
of therapeutic strategies that leverage draining lymph nodes in coordinating anti-tumor immune response and
improve outcomes in HNSCC and other solid tumor patients.

Public health relevance
Project Narrative Cancer immunotherapies have led to major treatment breakthroughs for a number of different cancers, but the majority of head and neck cancer patients do not respond to immunotherapies, and clinical responses are often not durable. We have demonstrated that targeting tumors with stereotactic radiation in combination with immunotherapy while sparing draining lymphatics enhances anticancer immunity, resulting in significantly improved response profiles. The research outlined in this proposal will leverage targeted tumor radiation in combination with optimized immunotherapy in a particularly lethal form of head and neck cancer to improve clinical outcomes for both tumor control and treatment toxicity, using both animal models of head and neck cancer as well as data from clinical trials of combination targeted radiation and immunotherapy.